Promoting Research Training During Psychiatry Residency

Abstract
This is a competitive continuation application of our Brown University R25 program “Promoting Research
Training During Psychiatry Residency.” Exciting advances in basic and clinical psychiatry/neuroscience and
genomics hold the promise of revealing the causes and potential new treatments for mental illnesses.
However, a critical shortage of physician-scientists poses a threat to our ability to advance and translate
discoveries from basic science into effective prevention and treatment approaches. The overarching goal of
our Research Training Program (RTP) is to train the next generation of psychiatry residents to design and
conduct rigorous, innovative and impactful research and develop successful careers as independently funded
research-oriented physician-scientists in psychiatry/neuroscience. In the first five years of this program we
have achieved our recruitment and training goals, and our residents have been remarkably successful with
their research and early career development. Conducting innovative and rigorous research, our RTP residents
have presented and published their findings widely and in top-tier journals. RTP residents have successfully
competed for travel and poster awards, and their research projects have been funded by numerous national
and local research funding awards. Our program combines an intensive longitudinal mentored research
experience with an individualized research didactic curriculum and career development activities in a rich,
multidisciplinary environment at Brown University. The cohesive program leadership team and Advisory
Committee balance research and clinical training, monitor research and career development progress, and
solicit feedback for program improvement. This application seeks to carry out the following aims: 1) Continue to
recruit and train highly-qualified psychiatry residents to develop independent research careers, and 2) Build
upon our existing successful program to further support resident research and career development with new
and innovative components. Continuation of funding for this program would enable us to train 10 research-
focused residents (two per year) over the next 5 years, thereby expanding the number of highly trained
physician scientists in research domains central to the NIMH mission. The outstanding research training
environment in psychiatry and brain science at Brown, characterized by internationally recognized, externally
funded, innovative research programs and investigators, cross-disciplinary collaborations, and exceptionally
well-qualified and dedicated mentors, makes our psychiatry residency an ideal environment in which to train
the next generation of physician-scientists in psychiatry and neuroscience.

Public health relevance
Project Narrative Recent exciting developments in psychiatry and neuroscience hold great promise for our understanding of the causes and treatments for mental illness. However, a critical shortage of physician-scientists limits our ability to advance this science and translate discoveries into effective prevention and treatment strategies. This application seeks to continue support for a psychiatry residency research training program that aims to increase the number of physician-scientists conducting innovative and rigorous research on the causes and treatment of psychiatric disorders.